The Effectiveness of Public Policy Interventions in Reducing Racial Disparities in Drowning: Lifeguard Certification, Pool Regulations, and Swimming Instruction Programs

PROJECT SUMMARY/ABSTRACT
Drowning is a leading cause of unintentional injury-related death for children and young adults. Although
drowning rates fell from 1.9 per 100,000 in 1999 to 1 per 100,000 in 2019 among persons under 18, wide racial
gaps persisted in fatal drowning rates. In some states, the Black-White gap has nearly vanished, while it has
widened among other groups, like American Indians and Alaskan Natives. Among Hispanics, drowning rates,
lower nationally than those for Whites, have been rising. The response by public policymakers at the state and
local levels has been to introduce an array of interventions, from free learn-to-swim programs to increased
regulations of pools and lifeguards. Unfortunately, systematic evaluation of these policy interventions and
assessment of the impacts these interventions may have had on racial disparities in drowning remains elusive.
This project's overarching objective is to better understand which public policies to reduce drowning deaths and
injuries work and for whom. This proposal examines three types of public policy interventions designed to reduce
accidental deaths or injuries due to drowning and undertaken at various times and in different locations around
the U.S. over the past 20 years: a) local government and school district learn-to-swim incentives, b) swimming
pool standards, and c) lifeguard certification and staffing requirements in public and private facilities. To assess
the effectiveness of these policy interventions, the project team will create a national database of state and local
legislation, mandates, certifications, regulations, and locally funded interventions to reduce or prevent drowning.
The database will be merged at the county level with the restricted-use National Center for Health Statistics
(NCHS) mortality data and contextual data collected from public sources from 1989 to 2019. The merged
database will map separately by age, race, gender, and ethnicity, changes in the number of drownings before
and after the implementation of specific types of public learn-to-swim initiatives, swimming pool regulations, or
lifeguard mandates or certification requirements. By the end of the project period, the detailed list of state and
local policy indicators, the contextual variables obtained from public databases, and the code for linking to the
restricted NCHS data will be made publicly available through the ICPSR Data Archives. The project has three
Specific Aims: (1) Characterize state and local policy interventions designed to reduce accidental deaths or
injuries due to drowning by describing what was delivered to whom, where, and for how long. (2) Isolate the
causal impacts of the measured public policy interventions from Aim 1 on drownings by age group, race, gender,
and ethnicity. This aim will test two hypotheses: (2a) that the impacts of policy interventions differ across groups
and (2b) that the interventions narrowed racial gaps in accidental deaths due to drowning. (3) Quantify the effects
of structural or systemic racism on fatal drownings. This exploratory aim will estimate how many lives would have
been saved had lifeguard hiring practices existed without historical barriers to entry or racial discrimination,
providing insights into how systemic racism might affect racial disparities in fatal drowning rates.

Public health relevance
NARRATIVE The proposed research will provide direct evidence for which intervention strategies are most effective in preventing drowning and/or improving outcomes after a drowning event. The results will inform a better understanding of structural and systemic inequities of drowning risk, policies and standards related to decreasing drowning risk, and increasing equity of drowning interventions and outcomes.